Open Chemistry Collaborative in Diversity Equity (OXIDE)

The purpose of the Open Chemistry Collaborative inDiversity Equity (OXIDE) is to organize and enable the chairs of research active chemisty departments to significatly improve the diversity of their departments.